Core A: Administrative Core

ABSTRACT
The Administrative Core (Core A) will provide overall oversight of the research proposed within this P01
Program Project. Core A is directed by Dr. Pawel Kalinski, the Principal Investigator of this Program. Dr.
Kalinski has direct work experience at the two participating institutions, Roswell Park Comprehensive Cancer
Center (RPCI; since February 2017) and the University of Pittsburgh (2000-2017). Dr. Kalinski will be assisted
by Ms. Judith Epstein, Director of Grant and Foundation Development at Roswell Park who will serve as the
overall P01 Program Manager providing Program oversight and coordination of interactions and
communications. The P01 Executive Committee will be composed of the leaders of the P01 Projects and
Cores.
Core A will be responsible for the overall supervision of the research within this Program Project performed at
Roswell Park and the University of Pittsburgh, data dissemination between its participants and to outside
entities, oversight of the Cores, the interactions with NCI and the Internal and External Advisors, along with
interactions with parallel program projects at Roswell Park and the University of Pittsburgh. Core A will
organize the quarterly meetings to review of Program progress, along with the Annual P01 Retreats. It will
closely interact with all Research Projects and all Cores of this highly-translational P01, and it will work
particularly closely with Core C (Clinical) to assure optimal integration of the clinical and laboratory aspects of
this clinically-oriented research program.
The Administrative Core has the following Specific Aims: 1) Financial management and Program grant
administration; 2) Coordination of interactions and Program meetings among the groups involved in the
Program; 3) Sharing of data and experience with other Program Projects at Roswell Park and the University of
Pittsburgh; 4) Integration of this Program with the clinical programs and existing shared resource cores at
Roswell Park and the University of Pittsburgh; 5) Coordination of Program meetings and facilitation of
interactions with the Internal and External Advisory Boards; 5) Communication with NIH/NCI, including the
preparation of annual progress reports and the and final Program Project report; and 6) Data dissemination to
other groups at Roswell Park, the University of Pittsburgh, outside partners and the scientific community and
general public.

Public health relevance
PROJECT NARRATIVE The Administrative Core (Core A) will provide overall oversight of the clinical and laboratory research proposed within this clinically-oriented P01 Program Project. Core A is directed by Dr. Pawel Kalinski, the Principal Investigator of this Program. Dr. Kalinski has direct work experience at the two participating institutions, Roswell Park Cancer Comprehensive Cancer Center (Roswell Park) and the University of Pittsburgh. Core A will provide the overall supervision of the research within this Program Project, promote effective interactions with additional academic and biotech and pharma partners, data dissemination, the interactions with NCI and the Internal and External Advisors, along with interactions with concurrent program projects at the participating institutions.